The Impact of Frailty on Disease Relapse and Therapy Intensity in Older Adults with Acute Myeloid Leukemia: Biomarkers and Treatment Selection

Project Summary/Abstract:
Acute myeloid leukemia (AML) is a cancer of the blood and bone marrow that primarily occurs in older
adults (60 years and older). The incidence of myeloid neoplasms increases with age, peaking beyond 75
years. In the U.S., there are approximately 20,000 new patients diagnosed and 10,000 deaths due to AML
every year, and only 10% of older adults will survive 5 years after diagnosis. The overall incidence in the U.S.
has been rising about 1.5% each year, reflective of an aging population. Patients with AML over 60 years old
have significantly worse survival compared to younger patients with AML. Since the 1970's, the standard initial
therapy involves high-intensity induction chemotherapy with cytarabine, given over 7 days, and daunorubicin,
over 3 days, (i.e, 7+3) to achieve remission. For most older adults with AML, chemotherapy is not curative and
must be followed by consolidative allogeneic hematopoietic stem cell transplantation (HCT) with the goal of
cure. However, many older patients are considered ineligible for high-intensity induction and HCT due to
excess treatment-related mortality (TRM). This results in a great disparity: those most affected by AML are
often considered ineligible for its treatments due to their age. A novel intermediate-intensity treatment
approach, the combination of azacitidine and venetoclax (aza/ven), has transformed the treatment of older
adults with AML. FDA-approved in 2020, aza/ven results in a 68% complete remission (CR) rate for patients
over the age of 70 with newly diagnosed AML and has been given up to the 9th decade of life. Aza/ven has
allowed a greater number of older adults to achieve CR and thus be eligible for consolidative HCT. However,
the optimal treatment for older and/or frail adults with AML has yet to be established, including the choice of
high-intensity (7+3) vs. intermediate-intensity (aza/ven) initial chemotherapy and the personalization of HCT to
individual older patients. Despite the growing interest in incorporating geriatric assessments into decision-
making, no standard geriatric assessments have been broadly tested or adopted in adults with AML. In prior
analyses that form the background for this proposal, I established that Fried's frailty phenotype (FFP) was
associated with overall survival in both patients 60 years and older with newly diagnosed AML and in patients
undergoing consolidative HCT. Fit older adults had excellent survival, but pre-frail and frail patients died more
frequently from disease-related deaths. This raises several key follow-up questions: 1) Why are disease-
related deaths rather than treatment-related deaths associated with frailty? 2) Do pre-frail and frail patients fare
better with less intensive induction chemotherapy? and 3) Are there biomarkers that correlate with both frailty
and disease biology to explain this association? In this proposed project, I will answer these questions.

Public health relevance
Project Narrative: The incidence of acute myeloid leukemia (AML), a devastating and often lethal cancer that predominantly affects older adults, is increasing every year. As part of my previous work, I discovered that Fried's frailty phenotype is associated with overall survival and relapse in older adults with AML and those undergoing allogeneic hematopoietic cell transplantation. To determine why relapse is greater in frail patients, the optimal treatment intensity by frailty status, and the biologic pathways contributing to frailty and disease aggressiveness, we will expand that observational study to allow multivariate modeling and perform biomarker analyses using ongoing and previously banked blood samples.